Identifying Novel Photic Inputs to the Drosophila Circadian/Arousal Neural Network for Behavioral Manipulation

PROJECT SUMMARY/ABSTRACT
Mosquito disease vector control relies mostly on toxic insecticides. A more environmentally friendly
alternative is to make use of light-based behavioral manipulation to attract pests to traps and repel pests away
from human habitation. The present technology is based on the assumption that mosquito UV light detection
occurs solely through opsin-based photoreception in the eyes. The Holmes Lab has recently found additional
UV and short wavelength photoreceptive elements expressed in central brain neurons that strongly modulate
complex insect behavioral responses to light. Therefore, there is a need to incorporate these additional elements
in disease vector control designs for improved efficiency. Namely, CRYPTOCHROME (CRY), which is classically
associated with its role in circadian clock resetting, activates with blue- and UV- light and increases the electrical
excitability of circadian/arousal neurons. Based on my preliminary data, I hypothesize that CRY coordinates with
other photoreceptors to mediate light-induced electrical excitability of neurons, which underlie complex
sleep/wake and circadian modulated avoidance/attraction behaviors.
My objectives are to determine the mechanism of CRY phototransduction, how we can manipulate that
mechanism along with other light inputs to modulate complex behavioral responses to light, and if we can
translate that knowledge to a mosquito system for light-based control. I will begin by examining the molecular
phototransduction mechanism that underlie CRY-mediated electrical excitability of circadian/arousal neurons in
Aim 1. Next, I will measure the relative contribution of different photoreceptor inputs that mediate the
electrophysiological photoresponse in circadian/arousal neurons in Aim 2. Last, I will examine the molecular
phototransduction mechanism and photic response of transgenic Drosophila expressing day-versus night-biting
mosquito CRYs in Aim 3. My research will be useful for developing innovative LED devices for species-specific
harmful insect control in the ongoing fight against vector-borne diseases.
My Sponsor, Dr. Todd Holmes, and I have developed a training plan to focus on the development of my
technical, writing and communication, and mentorship skills. Development of my technical skills will focus heavily
on electrophysiology, behavioral assays, and microscopy. I plan to register for relevant courses, attend
workshops and training events, and network with experts in the field. Development of my writing and
communication skills will be accomplished by applying for grants/fellowship, manuscript development, and
presenting at conferences and symposiums. Additionally, I will develop my mentorship skills by training
undergraduate students to help run experiments and analyze data. I am a part of a highly collaborative research
environment, with many experts in electrophysiology, neurobiology and behavior, microscopy, genetics, and
bioinformatics within my department. I plan to fully utilize the resources and facilities available to me in order to
accomplish the goals of this proposal, as well as achieve my goal of becoming an independent research scientist.

Public health relevance
PROJECT NARRATIVE/RELEVANCE Cryptochrome and rhodopsin phototransduction leads to many light-modulated behavioral responses in Drosophila, including circadian entrainment and avoidance/attraction. Mosquitos are major disease vectors that seem to also rely on the same mechanisms of light response behavior. Understanding these phototransduction mechanisms could lead to the development of light-based control devices that attract or repel insects with improved efficacy and design.